Variants underlying sex bias in Systemic Lupus Erythematosus

ABSTRACT
Systemic Lupus Erythematosus (SLE) is an autoimmune disorder that is heavily biased 9:1 towards females.
Sex bias in SLE reflects both hormonal and sex chromosome differences between men and women. This
proposal focuses on identifying and functionally establishing genetic variants on the X chromosome that
contribute to SLE sex bias. Current efforts to understand the genetic architecture of lupus using genome-wide
association studies (GWAS) have identified variants at 13 X-linked genes that are associated with SLE. However,
causative variants at these loci remain unknown. These GWAS loci may contribute to female bias in SLE if
they influence how genes respond to X chromosome inactivation (XCI), the early developmental process that
epigenetically silences most X-linked genes in females in order to maintain dosage equivalence with males.
Although XCI represses most genes on one X in females, some genes escape XCI and are expressed from both
active and inactive Xs. XCI states for >20% of human X genes are variable, and escape XCI from a subset of
Xs, but are silenced in other females. Our recent data indicate that heritability at genes that variably escape XCI
is enriched in sex-biased disorders including SLE. We hypothesize that causal variants on the X
chromosome underlie aberrant inactive X expression in SLE. The objective of this proposal is to identify
these causal variants and directly evaluate their response to XCI. To address this hypothesis, we propose in
Aim 1 to fine map causal variants on the X chromosome and identify causal genes. Integration of results with
eQTL and functional genome annotation will further refine loci and link to causal genes. Association effects will
be compared between males and females to further differentiate those likely influenced by X inactivation. In Aim
2 we will functionally evaluate variants mapping to Xq28 for altered gene response to XCI and B cell expression.
We will perform multiplex reporter gene assays as an initial screen for functional variants with regulatory
potential. We will also establish a novel system to functionally evaluate X chromosome variants by editing stem
cells that will be differentiated to B cells and undergo XCI. We expect that results from experiments will be the
first to provide a critical functional link between associated variants and X chromosome inactivation,
and as such will have a profound impact on understanding mechanisms of SLE and lupus biology.

Public health relevance
PROPOSAL NARRATIVE Systemic Lupus Erythematosus (SLE) is an autoimmune disorder of significant public health relevance, affecting more than 1.5 million Americans, the vast majority of which are women of childbearing age. We propose to identify genetic variants on the X chromosome that contribute to sex bias in SLE and to develop novel systems to directly address their role on the X chromosome and in SLE. Results from this study have potential to provide new knowledge on SLE biology, X chromosome inactivation regulation and to identify novel targets for therapeutic development.